Enhancing PREP Evaluation Capacity using a Culturally Responsive, Equitable, and Sustainable Approach

The Project Summary/Abstract attachment is not required by either NOT- GM-21-024_ Notice of Special Interest (NOSI)_ Administrative Supplements to Enhance Program Evaluation Capacity, or FOA PA-20- 272; this placeholder is to resolve errors generated by Cayuse system-to- system solution for purposes of submission.

Public health relevance
The Project Narrative attachment is not required by either NOT-GM-21- 024_ Notice of Special Interest (NOSI)_ Administrative Supplements to Enhance Program Evaluation Capacity, or FOA PA-20-272; this placeholder is to resolve errors generated by Cayuse system-to-system solution for purposes of submission.